Role of M1 Cytokines in the Progression of Chronic Kidney Disease

Macrophages can have profound effects on the progression of chronic kidney disease (CKD) via the secretion
of pro-inflammatory “M1” cytokines including tumor necrosis factor- (TNF) and Interleukin-1 (IL-1). In the
previous cycle, we established that the transcription factor Krüppel like factor 4 in macrophages limits kidney
damage and fibrosis by suppressing macrophage TNF expression. However, TNF and IL-1 are also produced
by renal tubular cells (RTCs), and our preliminary studies have identified 2 factors in RTCs, A20 and Porcupine
(PORCN), that together constrain local TNF and IL-1 generation and ameliorate CKD. A20 is a ubiquitin editing
protein that downregulates NF-b signaling in myeloid cells and thereby protects against autoimmunity. In our
preliminary studies using murine models of inflammation- and toxin-induced renal injury, deletion of A20
selectively from RTCs (A20 KKO) permits enhanced local TNF and IL-1 expression and exacerbations in RTC
damage. We therefore hypothesize that A20 in the nephron protects against tubular damage and subsequent
CKD by constraining local generation of TNF and IL-1. To test this, we will subject A20 KKO and littermate
controls to models of chronic renal tubular injury. We recently reported that TNF in RTCs induces several Wnt
ligand isoforms and that the secretion of Wnt ligands permitted by the O-acyl transferase Porcupine exaggerates
obstruction-induced renal fibrosis. By contrast, in other models featuring proximal tubular injury Wnt signaling
can protect against CKD progression, and in our preliminary studies, inducible nephron-specific deletion of
PORCN upregulates renal TNF expression and exacerbates nephrotoxic serum nephritis (NTS). As restoring -
catenin signals can protect the proximal tubule, a key site of TNF-induced injury, we posit that PORCN in
proximal tubular cells suppresses TNF expression and thereby limits the severity of CKD. To test this hypothesis,
we will subject mice lacking PORCN in the proximal tubule (PORCN PTKO) to our tubular injury models. Our
preliminary studies indicate that deleting TNF from the proximal tubule (TNF PTKO) mitigates toxin-induced
tubular damage and prevents cell cycle arrest. Thus, to directly interrogate whether PORCN-dependent secretion
in the proximal tubule limits CKD severity by suppressing TNF-induced cytotoxicity, we will compare the
susceptibility to RTC damage of PORCN PTKO mice and mice harboring double PORCN and TNF deletion
restricted to the proximal tubule (Dual PTKO). We predict that interrupting TNF’s actions in the proximal tubule
will abrogate the augmented susceptibility to CKD accruing from PORCN deficiency in the proximal tubule. With
our integrated approach, we will elucidate nephron-specific pathways upstream and downstream of TNF that
can be targeted for the amelioration of CKD.

Public health relevance
Chronic kidney disease (CKD) is an independent risk factor for cardiovascular disease that afflicts large numbers of veterans and leads to severe cardiovascular complications including end-stage kidney disease. Most forms of chronic kidney disease (CKD) that feature persistent tubular damage progress to organ failure. Treatments that curtail chronic tubular injury are therefore desperately needed. The realization that pro- inflammatory cytokines contribute to tubular damage in sterile forms of kidney disease presents an opportunity to develop novel therapies for the prevention of end-stage kidney disease. The proposed studies will examine regulatory factors specifically in the kidney tubular cell (KTC) that constrain inflammatory mediator induction both within the KTC and in infiltrating immune cells. Identifying these factors will benefit the veteran’s population by leading to the rational design of potent, immune-directed therapies to prevent and/or slow the progression of CKD.